"Eye-tracking and Multimodal Biomarkers to Enhance Detection of Preclinical Alzheimer's Disease in Diverse Populations."

PROJECT SUMMARY/ABSTRACT
The proposed research seeks to address a critical need for cognitive screening tools that are sensitive to early
neurocognitive decline in preclinical Alzheimer’s disease (AD), suitable for application in racially/ethnically
diverse communities, and translatable across home, community, and primary care settings. Due to intricate links
between the oculomotor system and the medial temporal lobe, an initial site of tangle pathology, memory-related
eye-movements represent a promising method for assessment of medial temporal lobe function while minimizing
confounds (e.g., language proficiency, literacy, stereotype threat) associated with overt responding in traditional
cognitive tests. However, the sensitivity of memory-related eye-movements to incipient AD in cognitively
unimpaired older adults remains unclear. To address this critical gap in AD research, the applicant will leverage
a sample of 199 older adults in the Stanford Aging and Memory Study with existing cognitive assessments, CSF
and blood samples, MRI, and Tau PET data. During the K99 phase, the first aim is to examine associations
between memory-related eye-movements and global AD biomarkers including (a) CSF Ab42/40 and p-tau181
and (b) plasma p-tau181 in cognitively unimpaired older adults. The second aim is to examine associations
between these eye-tracking assays and focal tau accumulation in the medial temporal lobe using F18PI-2620
Tau PET imaging. The primary hypothesis is that two forms of memory-related eye-movements – novelty
preference and scanpath reinstatement – will be impaired in Ab+ individuals with elevated CSF and plasma p-
tau181, and will be negatively associated with focal tau accumulation in the medial temporal lobe. To accomplish
these goals and prepare for the R00 phase, the applicant will leverage existing strengths in the cognitive
neuroscience of memory and aging, statistical modelling, and MR imaging processing and analysis, to gain
expertise in 3 key areas: (1) eye-tracking measures of medial temporal lobe function, (2) analysis and application
of in vivo AD biomarkers (i.e., Tau PET imaging and blood-based biomarkers), and (3) racial and ethnic
disparities in AD research. The development of these skills will enable the applicant to successfully transition to
independence in the R00 phase, where they will complete the final aim, which will use a mobile eye-tracking
system to examine associations between memory-related eye-movements and blood-based biomarkers in a
racially/ethnically diverse sample of older adults. In doing so, this aim will also establish the feasibility of eye-
tracking data collection in home and health care settings. This project thus leverages multiple innovations that
work to increase the availability and accessibility of AD research to communities that are currently
underrepresented and underserved. For the applicant, this program will facilitate the rapid development of critical
skills and enable the successful launch of an independent research program that combines cutting-edge fluid
and imaging AD biomarkers and innovative neurocognitive assessment to mitigate disparities in AD research.

Public health relevance
PROJECT NARRATIVE Developing sensitive and unbiased tools for early detection of preclinical Alzheimer’s disease is critical for improving risk assessment, particularly in racial and ethnic minority groups that are underrepresented in Alzheimer’s disease research. The proposed research will examine the sensitivity of memory-related eye- movements –– a passive tool that can provide an index of medial temporal lobe functional integrity –– to blood- based and neuroimaging biomarkers of Alzheimer’s disease in cognitively unimpaired older adults. Critically, by establishing the feasibility of this approach across home and health care settings in a diverse older adult sample, this research will increase the availability and accessibility of research participation to diverse communities that are at increased risk for clinical Alzheimer’s disease.